Identification of Novel Variants And Genes Causing Thoracic Aortic Disease

PROJECT SUMMARY/ABSTRACT
IDENTIFICATION OF NOVEL VARIANTS AND GENES CAUSING THORACIC AORTIC DISEASE
Aortic diseases are among the top 20 causes of death in the US. Thoracic aortic aneurysms are rarely
symptomatic and often not detected until they dissect or rupture. One fifth of all cases of thoracic aortic aneurysm
and dissection (TAAD) are familial, and 20-30% of these are associated with a known, germline genetic variant.
The other 70-80% may be due to genes not yet identified. Identifying disease-causing variants and novel risk
genes is important for preventing aortic-related complications or deaths by identifying at risk family members. In
preliminary studies, we conducted exome sequencing in 303 TAAD patients and identified pathogenic variants
in genes known to cause TAAD in 3% of patients and variants of uncertain significance (VUS) in 26%. We
hypothesize that: (1) Many of our identified VUS are disease-causing pathogenic variants and many other new
pathogenic variants in known TAAD risk genes are likely to be discovered, and (2) There are additional novel
genes causing TAAD in our cohort. The aims of the study are to: (1) Identify potential pathogenic variants in
known or candidate TAAD risk genes by integrating genomic and clinical data; (2) Characterize cell-type specific
gene expression patterns in the normal developing mouse ascending aorta; (3) Identify novel TAAD risk genes
through case-control association of rare damaging variants and integrative analysis of genetic and transcriptomic
data and characterize clinical phenotypes of patients carrying mutations in novel risk genes. For this project,
DNA samples for a total of 1507 patients with TAAD have been collected and are currently undergoing exome
sequencing. We will use novel in silico predictors of pathogenicity and family segregation studies to assess
variants in known TAAD risk genes. To identify novel TAAD risk genes, we will use statistical methods to integrate
case-control association of rare damaging variants with gene expression data. In particular, we will quantify gene
expression through bulk and single cell RNA-seq of developing ascending aorta in E15.5 mice, and then identify
cell types associated with TAAD by analysis of known and candidate genes with cell-type specific expression. In
parallel, we will compare cases with a large set of population controls with comparable exome sequencing data
in case-control association analysis. Finally, we will use expression level in relevant cell types to further improve
the power and sensitivity of risk gene identification, with the hypothesis that true risk genes are highly expressed
in one or multiple cell types relevant to the disease. For novel candidate risk genes, we will characterize the
clinical phenotypes of patients who carry damaging variants in these genes. This study will provide training in
human genetics, computational genomics, and precision medicine to gain expertise in analyzing large-scale
genomic data derived from DNA- and RNA-sequencing and will apply these skills to identify novel disease-
causing genes for thoracic aortic aneurysms.

Public health relevance
PROJECT NARRATIVE This study aims to identify disease associated variants in genes known to cause thoracic aortic aneurysm and dissection (TAAD) as well as to identify new genes responsible for TAAD. We plan to study a cohort of 1507 affected patients using genomic analysis that integrates clinical and exome sequencing to identify novel candidate risk genes for TAAD. Thoracic aortic aneurysms are typically asymptomatic, and identification of disease-causing variants and novel genes for TAAD has important clinical implications for preventing deaths and aortic-related complications in asymptomatic individuals.